Molecular Mechanisms Underlying Yeast Transcription Circuit Evolution

Project Summary/Abstract
The rewiring of transcriptional circuits over evolutionary time is a major source of biological
novelty. This proposal seeks to determine the detailed molecular mechanisms that underlie
transcriptional rewiring using unicellular yeasts as a model system. The strategy is based on
direct experimentation in many different yeast species in the Saccharomycetaceae lineage, and
utilizes mutant construction, genome-wide transcriptional profiling, chromatin
immunoprecipitation, phylogenetic comparisons, and ancestral protein reconstructions. Circuit
comparisons among these yeasts will uncover specific examples of transcriptional rewiring, and
deeper analyses will reveal the molecular mechanisms by which the wiring changes occurred.
Although much rewiring is probably neutral, some of it appears adaptive: indeed, a major
mechanism for evolutionary novelty involves rewiring transcriptional circuitry to allow new
expression patterns of existing gene products. Thus, to truly understand the structures of
transcription circuits in modern species, we need to know the mechanisms by which they rapidly
evolve and how these mechanisms lead to and, thereby can account for, modern structures.

Public health relevance
Project Narrative A cell carefully regulates the transcription of each one of its many genes. In humans, abnormalities in this complex process (whether inherited or acquired) can lead to many diseases, including a variety of cancers. Plasticity in the way cells regulate their genes is a major source through which different species express their different characteristics, and it also takes place in the progression of normal cells to cancer cells; a deeper understanding of how transcription circuits evolve will provide insights into recognizing how it leads to aberrant physiologies.